The ubiquitin proteasome system in ER quality control

Project Summary/Abstract
Folding and assembly of proteins synthesized in the endoplasmic reticulum is
closely monitored by a quality control apparatus that diverts folding-defective
products to the cytosol to be degraded by the ubiquitin-proteasome system by a
process known as endoplasmic reticulum-associated degradation (ERAD). The
long-term goal of this project is to elucidate the mechanisms by which ERAD
recognizes and destroys its targets. In the previous funding period we
successfully implemented a large scale functional genomic analysis of the
mammalian ERAD system that allowed us to perform unbiased analysis of
substrate-selective ERAD in mammals. These data led to critical discoveries
about the mechanisms of substrate triage and delivery to the HRD1
dislocon/ligase and the role of unconventional ubiquitin conjugation in coupling
dislocation to degradation. The studies proposed in the present application
harness state-of-the-art technologies that extend these discoveries and if
successful will bring about a detailed molecular-level understanding of triage and
quality control in the early secretory pathway.
!

Public health relevance
Project Narrative: Protein quality control (PQC) is the process by which cells monitor and maintain the conformational integrity of their proteome and defects in PQC underlie the pathogenesis of many human diseases. PQC systems ensure that proteins which fail correctly fold or assemble are recognized and degraded by the ubiquitin-proteasome system (UPS). This proposal seeks to elucidate the molecular mechanisms by which such folding-defective proteins are recognized and handed off to the UPS.